CO Releasing Organic Polymers for Biomedical Applications

PROJECT SUMMARY/ABSTRACT
Over the last several decades it has become apparent that carbon monoxide (CO) gas is an important small
molecule that greatly impacts human health. Indeed, CO is created endogenously in small concentrations and
has been shown to be an essential signaling molecule in the human neuronal system. Moreover, CO gas has
been revealed to be a valuable therapeutic, specifically, it can ameliorate acute and chronic inflammation, can
reduce rejection of organ transplants, and can treat cardiovascular diseases. However, the direct study or use
of CO in biological systems is inherently complex because it is a gas, has limited solubility in water, and is toxic
at high concentrations. As such, many of the mechanisms and pathways by which CO operates in the human
body remain elusive. In response to these complications, CO Releasing Molecules (CORMs) have emerged as
a class of materials that can release CO in response to an external stimulus. As transition metals readily ligate
to and release CO under various conditions, these materials were the first class of CORMs developed and remain
the most popular and frequently utilized to date. Unfortunately, CORMs based on transition metal carbonyl
complexes are cytotoxic, form poorly defined products following release of CO, and cannot be directly
polymerized to form macromolecular targeted therapeutics. Research in the Worrell laboratory is inspired by the
shortcomings in current CORM technology, and we are actively engaged in creating stable, modular, and efficient
organic CO releasing molecules. Our work has been concentrated on analogs of diphenylcyclopropenone
(DPCP), a uniquely stable and bio-orthogonal molecule that features a highly strained 3 membered ring. Previous
work in a small molecule setting has shown that DPCP is unrivaled in its ability to cleanly and efficiently produce
CO gas. Proof-of-concept demonstrations have shown that analogs of DPCP can be effectively synthesized, can
be directly polymerized, and can release CO gas by photolysis, however, for application as a CORM, this must
be demonstrated in a biological system. Future work over the five-year course of this program will concentrate
on the development of methods for the controlled polymerization of DPCP to create tailored macromolecular
materials that are soluble, targeted, non-toxic, and biocompatible. We will further concentrate on improving the
rate and efficacy of CO release by leveraging the unique photophysics of DPCPs while creating well-defined
photoproducts. Ultimately, the most impactful extension of this work will be related to its development in studying
and treating gastrointestinal inflammation as part of a long-term collaboration with the Colgan/Onyiah group at
the University of Colorado Medical School. Although there are significant challenges associated with this
program, its scientific impacts will be far-reaching. If successful, organic CORMs will supersede those based on
transition metal complexes, stimulating the development of new targeted therapeutics based on the production
of CO gas.

Public health relevance
PROJECT NARRATIVE Carbon monoxide (CO) gas has been identified as an essential signaling molecule in the human neuronal system and has been shown to have many therapeutic applications. Molecules that create CO gas upon activation with an external stimulus are commonly dubbed CO releasing molecules, or CORMs, and have shown to be vital tool in studying the effect of CO in biological systems. This research proposes to create a new class of CORMs based on organic molecules that efficiently produce CO gas, are directly polymerizable, and have predictable and well-defined products following the release of CO, attributes not currently accessible with state-of-the-art CORMs.